Leadership, Planning and Evaluation

Program Director/Principal Investigator (Last, First, Middle): Chu, Edward
LEADERSHIP PLANNING AND EVALUATION - PROJECT SUMMARY/ABSTRACT
Edward Chu, MD, was named the 4th Director and first Vice President of Cancer Medicine at the Montefiore
Einstein Cancer Center (MECC) in October 2020. With this appointment, Dr. Chu was given expanded executive
leadership authorities, and is responsible to set mission, vision, and strategy, and position the MECC as a
comprehensive, integrated cancer enterprise between the Albert Einstein College of Medicine (Einstein) and
Montefiore Medicine (Montefiore). Since his arrival, Dr. Chu has transformed the MECC and expanded the
CCSG Senior Leadership Team (SLT) with two deputy directors and eight associate directors, all experts and
experienced leaders in their respective fields. Each leader has well-defined roles and responsibilities that
includes accountability and responsibility for planning and evaluation efforts at the MECC. The SLT has diverse
representation across all strategic scientific areas and cancer disciplines to catalyze transdisciplinary
collaborations and translational research, while engaging the community and nurturing an environment of
inclusion and belonging. MECC leaders are highly engaged as a mission-driven team and work collaboratively
to serve, lead, govern and execute on all strategic initiatives. Leaders participate and collaborate via 10 internal
committees, 2 external advisory boards, and 8 Strategic Working Groups to enhance planning and evaluation
efforts. The SLT has developed and implemented an operational structure and schedule designed and aligned
to meet and exceed the milestones and tactics defined in the new 2021-2026 MECC Strategic Plan – to date
over 60% of the goals have been realized. Since the previous CCSG review in 2019, the SLT has facilitated and
led several transformative processes, which include: (1) integrated four scientific cross-cutting themes across all
areas of the cancer center; (2) appointed 8 new Program Leaders; (3) restructured Research Programs to more
tightly align and focus cancer research, and effectively foster transdisciplinary collaboration and translational
research; (4) tightened MECC membership criteria to enhance cancer focus; (5) appointed a new Associate
Director for Diversity, Inclusion, and Equity (DEI) and launched a new DEI Committee; (6) re-established the
Community Advisory Board; (7) expanded Cancer Research Training and Education and launched new Bronx
High School Program – BEYOND Albert; (8) strategic shared investment in COE, CRTEC and CPDM Disease
Modality Teams to increase awareness and access to clinical trials. (9) convened 2 external ad hoc EAB
meetings focused on COE strategies and catchment area research and the second on reviewing progress to
date on strategies to enhance CPDM, DSM, clinical accrual and PRMS. To date, the Center Director and his
SLT have affected change that has resulted in renewed cancer focus, over ~1,000 patients participated in clinical
trials in 2021, 20% increase in cancer relevant funding and $33M in philanthropy.
OMB No. 0925-0001/0002 (Rev. 03/2020 Approved Through 02/28/2023) Page

Public health relevance
Program Director/Principal Investigator (Last, First, Middle): Chu, Edward LEADERSHIP, PLANNING AND EVALUATION - PROJECT NARRATIVE Per PAR-21-321, a Project Narrative is not required for this Component. OMB No. 0925-0001/0002 (Rev. 03/2020 Approved Through 02/28/2023) Page